Molecular mechanisms of evolution at the host-microbe interface

Project Summary
Microbes and their animal hosts encode numerous proteins to sense, manipulate, and
defend against each other. The outcome of these interactions can mean the difference
between a mutualistic exchange and a fatal infection. Epithelial surfaces provide the
point of first contact between hosts and diverse communities of commensal bacteria, in
addition to forming a critical barrier against bacterial pathogens. Although host and
microbial proteins at these interfaces can evolve rapidly between and within
populations, the impact of such diversity on immune defense is largely unknown. This
proposal will leverage host-microbe barrier interactions as models to investigate the
causes and consequences of adaptive protein evolution. We will first apply integrative
phylogenetic and experimental approaches to determine how diversification of epithelial
surface proteins mediates cell-cell adhesion and virulence of human-associated
bacterial pathogens. In a second line of study, we will identify how evolution of primate
secreted immunity proteins modulates bacterial destruction and defense functions.
These projects will also employ experimental evolution in the laboratory to trace
mechanisms of bacterial adaptation to antimicrobial enzymes in real time. This research
program will advance our fundamental understanding of evolving host-microbe systems
and accelerate strategies to diagnose and combat the growing threat of bacterial
infectious disease.

Public health relevance
Project Narrative The evolution of pathogenic microbes and animal hosts impacts resistance or susceptibility to infectious disease. Growing evidence indicates that molecular interactions between bacteria and host cells at epithelial barriers are crucial for human health, although the consequences of rapid evolution at this interface are unclear. This proposal will address how primate and bacterial proteins have evolved at the epithelial surface and the consequences for genetic variation on host immunity and disease.